CATECHOLAMINES IN OBESITY DURING FASTING AND REFEEDING WITH LOW CALORIE DIET

Body fat distribution may affect energy expenditure. A decrease of calorigenic response to a meal in obese subjects has been suggested as one of the factors that may predispose to weight gain. The objective of this study is to assess whether fat distribution effects dietary induced thermogenesis (DIT). The DIT was similar in five patients with different fat distribution that we have studied. We have completed this study and are evaluating the results.